Core E: Imaging Core

ABSTRACT
The imaging core for the program project grant “Frontotemporal Dementia: Genes, Images and Emotions” has
managed the acquisition, storage, distribution and analysis of brain imaging data since the initial funding of the
grant. Throughout the life of the project, the imaging core has ensured that images are properly acquired,
uniform in quality and that raw and processed images are shared with other PPG researchers and with the
other scientific collaborators. The imaging core has also led the development of many new processing
pipelines to support the scientific goals of the PPG. For the proposed fourth cycle of this PPG, the imaging
core will pursue the following aims: 1) Collection and archiving of images and maintenance of an image
database: We will collect and manage the following MRI sequences in age-matched patients with bvFTD,
nfvPPA, svPPA, CBS, PSPS, lvPPA, AD and age-matched participants with major depressive disorder (MDD)
and bipolar affective disorder (BAD): MP-RAGE, FLAIR, dMRI, ASL perfusion, tf-fMRI and T2-weighted MRI.
We will also acquire [18F]AV-1451 and [11C]PIB PET scans. Working with the data management core, we will
archive de-identified images on a server accessible to the rest of the PPG investigators and provide tools for
locating and retrieving images for analysis. 2) Image preprocessing: We will preprocess MR images including
RF field bias and geometrical distortion corrections. We will coregister each subject's dMRI, ASL, tf-fMRI and
PET images to their “native space” as defined by their MPRAGE, 3) Extraction of regional volumetric and
molecular data and creation of longitudinal change maps: We will process T1-weighted images with SPM to
derive regional gray matter volumes using standard cortical and subcortical regions of interest (ROIs). We will
derive regional tau PET and normalized amyloid tracer binding values for standard ROIs. We will create voxel-
wise maps for subjects with bvFTD, nfvPPA, svPPA, CBS, PSPS, lvPPA, AD, MDD and BAD quantifying 1-
year change in gray matter volume and tau PET signal (for those undergoing longitudinal imaging) in native
and standard spaces. Working with the data management core, we will make these values and maps available
to other PPG researchers on a secure server, and 4) Consultation on analysis: We will work with PIs and staff
serving the other PPG projects and cores on incorporating these and other imaging data into their analyses.

Public health relevance
NARRATIVE Brain imaging plays a critical role in research and clinical assessment of frontotemporal dementia and related disoders. The role of the imaging core for the program project grant entitled “Frontotemporal dementia: Genes, Images and Emotions” is to ensure that images used by other researchers on the project are uniformly high in quality and easily accessible, and that various procedures for analyzing the images are available for use by all researchers.